ABCD-USA Consortium: Data Analysis, Informatics and Resource Center

In this Administrative Supplement to the ABCD-USA Consortium: Data Analysis, Informatics and
Resource Center (DAIRC) we propose to develop a new infrastructure for data releases for the
Adolescent Brain Cognitive Development (ABCD) Study. The infrastructure is proposed to be
set up in time for the 6.0 data release in spring 2024 and is planned to be used for all future
data releases.
The core component of the new infrastructure will be a reimplementation and extension of the
Data Exploration and Analysis Portal (DEAP version 2.0) which will feature extended
functionality for data download, exploration, statistical analysis, and advanced visualization. The
DAIRC will lead the development of DEAP 2.0 and supporting efforts, including the development
of backend components, databases, storage infrastructure, and computing infrastructure. The
supplement will further support the DAIRC in the development of more streamlined and
standardized internal data management processes. As part of the development of the new
release infrastructure, the DAIRC will sub-contract to Lasso for the development of an
authentication server, a web portal to request access to the ABCD data resource, and download
functionalities for individual-level files.

Public health relevance
This supplement to the ABCD-USA Consortium: Data Analysis and Informatics Resource Center (DAIRC) proposes efforts to develop a new infrastructure for data releases for the Adolescent Brain Cognitive Development (ABCD) Study. The goal is to have the infrastructure set up in time for the 6.0 data release scheduled for spring 2024 and to use this infrastructure for all data releases going forward.